Healthy Mothers-Healthy Children: An Intervention with Hispanic Mothers and their Young Children

PROJECT SUMMARY
Hispanic women and children who become overweight or obese are at risk for developing prediabetes,
type 2 diabetes, and cardiovascular disease later in life. To date, there have been no interdisciplinary
interventions that have targeted Hispanic women and their 4-year old children to improve nutrition and
physical activity behaviors to manage adiposity and weight in mothers and prevent excessive adiposity and
weight gain trajectory in their children. Using a randomized two-group, repeated measures experimental
design, the goal of the proposed study is to investigate the efficacy of a 12-week nutrition and exercise
education, physical activity, coping skills training, and home-based physical activity intervention in Hispanic
women and their 4-year old children and 6 months of continued monthly contact to help overweight and
obese Hispanic mothers improve adiposity, weight, health behaviors (nutrition and physical activity), and
self-efficacy and their 4-year old children improve their adiposity and weight gain trajectory and health
behaviors (nutrition and physical activity). W e will partner with two federally qualified health departments
in Durham and Chatham, North Carolina to enroll Hispanic women and their 4-year old children and we
will partner with community centers to deliver the intervention. A total of 294 Hispanic women with a BMI
2
>25 kg/m and 294 Hispanic 4-year old children with a BMI percentile > 25 will be enrolled over 4 years
and randomized to the experimental or equal attention control group. Data will be collected at Time 1 (0
months [baseline]) to Time 2 (9 months [completion of the intervention]) and Time 1 to Time 3 (15 months
[after 6 months with no contact from the study staff]). Data collected will include adiposity (primary
outcomes: waist circumference, triceps and subscapular skinfolds) in mothers and children and weight
(primary outcomes: body mass index [BMI] in mothers and BMI percentile in the children). Secondary
outcomes will include health behaviors and self-efficacy in the mothers (Adult Health Behavior
Questionnaire, Lifestyle Health Promoting Profile II, 3 day 24-Hour Food Recall, and 7 day Accelerometer,
Eating Self-Efficacy Scale and Exercise Self-Efficacy Scale) and in the children (7 day Accelerometer and
3 day 24-Hour Food Recall). We will also evaluate the cost of delivering the program for public health
departments. Data analysis will use general linear mixed models to test the hypotheses. Decreasing
overweight and obesity in Hispanic women and slowing adiposity and weight gain trajectory in young
Hispanic children is urgently needed to decrease morbidity, mortality, and future health care costs. The
knowledge to be gained from this study may provide a foundation for extending this intervention to other
Hispanic mothers and children in other communities to assist mothers in managing their weight and
preventing excessive adiposity and weight gain in their children. This approach is translatable, real-world,
and could be replicated in other areas of the United States.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the prevalence of overweight and obesity is increasing in Hispanic women and young children. The goal of the proposed study is to investigate the efficacy of a nutrition and exercise education, exercise, coping skills training, home-based exercise in Hispanic women and the Color Me Healthy program in their 4-year old children. This project is relevant to NIH's mission since it will test new strategies to prevent and manage chronic disease in minority mothers and their young children.